Functional Analysis of NSV-based HIV vectors

DESCRIPTION (provided by applicant): Negative-stranded RNA virus (NSV) vectors have shown promise as vaccines against a variety of infectious diseases. While they have similar life-cycles, NSV vectors interact with and modulate innate immunity, such as type I interferon responses, by very different mechanisms. VSV is a highly cytopathic virus that shuts down cellular gene expression by virtue of its M protein. Rabies virus (RV) is a noncytopathic virus that down-modulates STAT function by virtue of its P protein. NDV is an avian paramyxoviruses that appears not to have specific mechanisms of down-modulating innate immunity in mammalian cells. All of these viruses replicate to different extents in vivo and elicit different host signaling programs in dendritic cells. Since it is unclear what constitutes an ideal vector for HIV vaccines, we will now compare these viruses and extract information on how their specific characteristics modulate immunogenicity. A comprehensive analysis of immunogenicity parameters induced by vectors with a similar backbone and replication cycle but with very diverse set of host-virus interactions has not been performed. The overall hypothesis for this application is that NSV vectors can be improved by altering their interactions with the innate immune system. We hypothesize that an effective HIV-1 vaccine must activate dendritic cells (DCs), which are an important link between innate and adaptive immunity. We will first study the impact of these vectors expressing HIV-1 antigens on DC-mediated immunity in-vitro, and identify parameters that would be expected to induce effective adaptive immunity in-vivo, such as efficient antigen presentation and activation. These initial studies will allow us improve the efficiency of our vectors, and provide us with a better basic understanding of what constitutes an optimal vector for the induction of HIV-1-specific immune responses. Once these parameters are determined, we will study the vectors for pathogenicity and immunogenicity in heterologous prime-boost approaches in mice. The most promising approaches identified in mice will be further analyzed in rhesus macaques.

Public health relevance
We develop and compare new viral vectors as HIV vaccine. A vaccine that prevents HIV infection or at least prevents AIDS would have a great impact on human health.